Building a patient-centered cancer data mart in a rural state

Abstract
The University of Iowa Holden Comprehensive Cancer Center (HCCC) is an NCI-funded comprehensive
cancer center with a strong culture of transdisciplinary collaboration. It is the only academic cancer center in
the state of Iowa and serves a rural population with unique environmental exposures. The Population
Research Core is a HCCC shared resource that provides centralized leadership for harnessing clinical and
population-based tools and data resources, eliminating barriers to their use. Led by its Director, Dr. Bradley
McDowell, the Core provides epidemiology expertise, study design, enhanced data sharing, and distributed
prep-to-research queries that promote rigorous retrospective and prospective studies using robust data
collection and data curation methods.
Dr. McDowell's expertise in these areas is particularly important as we apply big data approaches that
integrate social, population, clinical, patient-generated, and molecular data to generate evidence to personalize
cancer care. The ultimate goal is to provide researchers with a complete picture of cancer patients'
experiences prior to diagnosis, during treatment, and through long-term survival. This will be accomplished by
integrating existing hospital data with state cancer-registry data, insurance claims, and other cancer-related
datasets to create a multi-purpose data mart that will serve as a resource for standardized data queries. This
work will be performed while continuing to oversee a mature support core for population science activities of
the HCCC.

Public health relevance
1 Narrative This application requests funding that would concentrate a sustained specialized influence on patient and population-based cancer research at the University of Iowa Holden Comprehensive Cancer Center. The proposed support would increase the number of cancer researchers using big administrative, clinical and population-based data and tissue resources and increase speed and efficiency with which interdisciplinary teams become able to use these data for their research.